DPAC

SUMMARY: DATA PROCESSING AND ANALYSIS CORE (DPAC)
The overall goal of the Data Processing and Analysis Core (DPAC) is to provide consistent and cost-effective
expertise in biostatistics and research informatics for all projects in the proposed research program of the
University of Southern California Tobacco Centers of Regulatory Science (USC TCORS). Key functions and
support provided by DPAC include initial consultation on study designs, followed by provision of tools for survey
platform and database development, especially tracking and monitoring databases within projects and sharing
data across projects; generation of interim reporting on progress for each study; generation of cleaned, coded
(consistently across projects), and documented analytic datasets for each project, as well as initial univariate
and summary analyses for common data elements. The DPAC team consists of a multidisciplinary group of data
specialists and experts who are experienced in the collection, management, and analysis of longitudinal and
experimental study data, and reporting these in the published articles. The DPAC will support and facilitate inter-
disciplinary research by providing essential services related to data management, biostatistics, and integrated
analytics to enable modern data-driven investigations. Supporting informatics and biostatistical needs for a
diverse group of investigators will include: (1) working with the Administrative Core and Projects to create user-
friendly platforms for data collection and sharing; (2) demonstrating and optimizing the process of data accuracy
and usability through data cleaning and codebook development; (3) investigating project-specific hypotheses in
collaboration with project personnel using analysts and expertise from the Core; and (4) supporting study results
interpretation and publication of research studies. To achieve these goals, the DPAC has the following Specific
Aims: (1) To work with USC TCORS investigators to develop front-end survey platforms for capturing data and
back-end data processing mechanisms to optimize the timeliness, efficiency, accuracy, and usability of data;
and (2) To provide biostatistical methodological support for developing and implementing data analysis plans
and interpreting data.